Administrative Core

Abstract
The University of Minnesota (UMN) Udall Center Administrative Core, led by the Center Director Jerrold Vitek,
MD, PhD, supported by the Center Administrator Eric Maurer, MHA, will provide leadership, oversight, and
integration of the four UMN Udall Center Projects and three other Cores. The Center Director will monitor the
scientific progress of each Project at the weekly Center meeting. The Administrative Core will organize and
lead all Center meetings, produce the annual progress report, and communicate and coordinate research
discoveries and publications with NINDS and the local patient community. The Administrative Core will support
and track the individualized career enhancement plans for the Center’s cohort of Early Stage Investigators and
career development for students and trainees affiliated with the Center, including the annual career retreat and
the Pathways to Translation seminar. The Administrative Core will also lead the Center’s local and regional
Parkinson's disease (PD) community in-person outreach efforts, including organizing and hosting the annual
regional patient symposium, and digital outreach strategies. The Administrative Core will serve as the
organizational foundation of the UMN Udall Center.